Prebiotics to Optimize the Microbiota and Improve Outcomes of AllogeneicHematopoietic Stem Cell Transplantation

Hematopoietic stem cell transplant (HCT) has the potential to cure leukemia and other malignant and non-
malignant diseases. However, these processes are associated with significant morbidity, and treatment-related
mortality (TRM) ranges from 10-30%. This is largely due to graft-versus-host disease (GVHD), in which the donor
immune system attacks host tissues. GVHD has been linked to disruptions in the bacteria living in the gut (the
microbiota), which in turn may be caused by factors such as conditioning chemotherapy, radiation and antibiotic
treatment. GVHD and mortality are mediated by the immune system, whose activity in turn is shaped by gut
microbiota. Prebiotics are nondigestible fibers that can be safely given to HCT patients and metabolized by
existing bacteria in the gut to positively impact bacterial communities and metabolic products such as butyrate.
Butyrate is a short chain fatty acid that is an important energy source for colonic epithelial cells and can promote
regulatory T cell development, which in turn can modulate GVHD. Our preliminary data suggest that the
administration of the prebiotic galacto-oligosaccharide (GOS) to mice undergoing HCT, can both increase
butyrate and decrease GVHD. Here we propose the following aims: Aim 1. Evaluate the safety, tolerability, and
efficacy of GOS in a phase 1 and randomized phase 2 trial. Aim 1A: We will determine the maximum tolerated
dose (MTD) of GOS in a phase 1 dose escalation study (Years 1-2). We hypothesize that GOS is tolerable in
doses that increase bacterial diversity and butyrate levels. Aim 1B: We will evaluate the impact of GOS on HCT
outcomes in a randomized placebo-controlled phase 2 trial. (Years 2-5). We hypothesize that patients receiving
GOS will have better outcomes including decreased grade II-IV GVHD. Aim 1C: We will compare the pre-HCT
microbiome of GOS responders (those who received GOS in the phase 1 and phase 2 trials and had increased
bacterial diversity) and non-responders (those with no change or decreased bacterial diversity) to determine
elements of the pre-HCT microbiome that may be associated with GOS response. Aim 2. Evaluate the impact
of GOS on biomarkers of intestinal and systemic inflammation and GVHD as potential mediators of HCT
outcomes. The regenerating islet-derived protein 3 alpha (REG3A), is of particular interest. REG3A is an
antimicrobial peptide that may be affected by the microbiota and has been reported as a biomarker of GVHD.
We hypothesize that patients treated with GOS will have positive changes in biomarkers of inflammation and
GVHD (increased REG3A, primary endpoint). As an exploratory aim, biomarkers will be studied for their
associated with prebiotic interventions, changes in the microbiome, bacterial metabolites, immune reconstitution,
and HCT clinical outcomes (GVHD, TRM, OS). Our long-term goal is to understand how prebiotic interventions
impact the microbiota and bacterial metabolites and use prebiotics to decrease inflammation and improve HCT
outcomes. We expect that the data generated from this study will lead to future clinical trials, including a
multicenter randomized phase 3 trials, or to microbiota-based diagnostic assays to personalize therapies.

Public health relevance
We propose to evaluate the safety, tolerability, and efficacy of a pre- and peri-hematopoietic stem cell transplant (HCT) prebiotic intervention to improve the health of the gut microbiota (bacteria in the gut) and HCT outcomes. Our phase 1/randomized phase 2 clinical trial is accompanied by stool-based correlative studies to understand the impact of our prebiotic intervention on the microbiota and differences in the microbiota that may explain why some patients respond to the prebiotic while others may not; we also include peripheral blood biomarkers to identify potential mechanisms to explain the interaction between the prebiotic, microbiota, and HCT outcomes.